Somatic mosaicism across mouse tissues during different life stages

ABSTRACT
Somatic mosaicism arising from the accumulation of postzygotic DNA mutations in somatic cells (somatic
mutations), leads to tissue genetic heterogeneity. Somatic mutations occur at different life stages and throughout
an individual’s lifespan and are implicated in various human diseases, including cancers, monogenic diseases,
neurodegenerative disorders, cardiovascular diseases, autoimmune diseases, skin diseases, and liver diseases.
In addition, random somatic mutations were identified to accumulate with age in humans, and associated with
environmental and genetic risk factors, for example, tobacco smoking, UV radiation and BRCA1/2 deficiency.
However, it is still unclear whether somatic mutations are a cause of functional decline in human health, for
instance, aging, although the hypothesis was proposed in the 1950s, due to several critical knowledge gaps and
important challenges. Due to cell-to-cell heterogeneity, somatic mutations are unique in each cell of normal
tissues and are extremely difficult to detect accurately, which leads to the large unknown about somatic mutation
burdens per cell with respect to tissue types and life span in normal, non-cancer tissues of an organism. In
addition, the causes of somatic mutations and how they evolve in normal tissues during different life stages
remain unclear. With the experience and expertise in somatic mutations and genome instability, our goals for the
next five years is to utilize cutting-edge DNA sequencing technologies, including single-cell whole-genome
sequencing, Nanorate sequencing, and ultra-deep bulk whole-genome sequencing and computational analyses
to 1) quantitatively explore somatic mutation burdens in normal, non-cancerous tissues in mice across different
life stages; 2) identify mutational signatures and clusters, to infer molecular mechanisms and risk factors and to
guide experimental validation in the future; 3) decipher the patterns of somatic mutation evolution, examining
whether they are subject to random drift, positive selection or negative selection across tissue types and life
stages. Based on the new discoveries, for the long-term goals, I will explore the health relevance of mutation
burden, signature, and somatic evolution, quantify the risks of environmental factors, and develop new standards
for drug safety. Additionally, I plan to select specific genes or genetic regions (with either higher or lower mutation
burdens than expected) for testing their health relevance. These goals will be achieved using mouse as the
model organism for testing and developing new interventions. Overall, the proposed projects will provide
comprehensive insights into somatic mosaicism, laying the groundwork for understanding its role and the
mechanisms of its impact on biology and health and shedding light on future interventions.

Public health relevance
PROJECT NARRATIVE Somatic mosaicism has long been proposed to influence human biology and health in normal tissues, but it remains largely untested due to technical difficulties. The goal of this project is to utilize state-of-the-art methods including single-cell whole-genome sequencing, NanoSeq and ultra-deep bulk whole-genome sequencing to characterize the landscapes of somatic mutations in multiple normal tissues of mice during different life stages. The results of this study will provide comprehensive insights into somatic mosaicism in normal, non-cancer tissues, laying the groundwork for understanding its role in biology and health and guiding future interventions.